Deformability distributions in heterogeneous red blood cell populations

DESCRIPTION (provided by applicant): The unique ability of the red blood cell to deform and withstand the high shear stress in the circulation is lost with altered molecular interactions in te membrane or changes in the cytosol. We have developed a novel technique Single Cell Micro-chamber Array or SiCMA, to rapidly analyze heterogeneous cell populations, and plan to show that this technology will allow the correlation of deformation and fragility with cell surface and cytosolic markers in heterogeneous populations of red blood cells. We propose a multidisciplinary approach with experts from mechanical engineering, cell biology, and clinical hematology to develop a novel technology for red cell membrane biology and show its applicability for clinical diagnosis of patients with hereditary spherocytosis (HS). To reach this goal we have formulated the following specific aims: 1) To optimize deformation measurements in SiCMA chambers, 2) To compare SiCMA deformation analysis with established technology, and 3.) To test the new technology on samples relevant for red cell pathology. Successful accomplishment will lead to the establishment of a novel approach to rapidly and highly cost-effective, select, define, and correlate cellular markers of individual cells in a heterogeneous re cell population, to be used in laboratory assessment of basic research in membrane biology as well as for prognosis and treatment of red cell disorders.

Public health relevance
The unique ability of the red blood cell to deform and withstand the high shear stress in the circulation is lost with altered molecular interactions in te membrane or changes in the cytosol. Laboratory measurements of red cell to deformability provide the average deformation of a large population of red cells, or can determine this in limited numbers of individual red cells. We propose a multidisciplinary approach with experts from mechanical engineering, cell biology, and clinical hematology to develop a novel technology that will allow the determination of deformability and fragility of individual cells in large populations of red cells, and correlate deformation with both membrane and cytosolic markers. Successful completion of this project will provide a better assessment of heterogeneous red cell populations, important for cell biology and clinical diagnosis.